Highly selective detection of tau oligomers in biological fluids for the diagnosis of Alzheimer's Disease

This proposal is for a phase I/II fast track project for the STTR program with the main goal to develop a test for high sensitive detection of tau oligomers in biological fluids, which could be used for the biochemical diagnosis of Alzheimer’s disease (AD) and related tauopathies. AD is the most common dementia in the elderly population and one of the leading causes of death in the developed world. One of the main problems in AD is the lack of an early, sensitive and objective laboratory diagnosis to identify individuals that will develop the disease before substantial brain damage. Compelling evidences point that the hallmark event in AD is the misfolding, aggregation and brain accumulation of amyloid-beta (Aβ) and tau proteins. Recent evidences suggest that Aβ pathology is the primary driving force of the disease initiation, but this is accomplished by induction of tau hyperphosphorylation, misfolding and aggregation, leading to the neurodegenerative cascade. Tau aggregation follows a seeding-nucleation mechanism and involves several intermediates, including soluble oligomers and protofibrils. Recent evidence has shown that tau oligomers are circulating in biological fluids and these structures appear to be key for inducing brain degeneration in AD. Our working hypothesis is that detection of misfolded tau oligomers circulating in blood may be the basis for an early biochemical diagnosis for AD. Our approach is to use the functional property of misfolded oligomers to seed the aggregation of the monomeric protein as a way to detect them. For this purpose, we have developed the protein misfolding cyclic amplification (PMCA), which represent a platform technology to detect very small quantities of seeding-competent misfolded oligomeric proteins associated with various protein misfolding diseases. Currently, PMCA has been adapted to detect misfolded prion protein implicated in prion diseases in various biological fluids, including blood and urine and more recently soluble oligomers composed of Aβ and α- synuclein in cerebrospinal fluid (CSF) of patients affected by AD and Parkinson’s disease, respectively. The major goal of this project is to adapt the PMCA technology for specific and highly sensitive detection of misfolded tau oligomers in human CSF and blood plasma, perform studies of specificity and sensitivity using large number of samples coming from patients affected by AD and other tauopathies as well as to evaluate the utility of tau-PMCA for monitoring disease progression. The results generated in this project may lead to the first biochemical test for diagnosis of AD. The studies included in this project will constitute the basis for regulatory approval of the test that Amprion will commercialize.

Public health relevance
Development of a biochemical assay for the sensitive, early and non-invasive diagnosis of Alzheimer’s disease is a top medical priority, essential to permit efficient treatment of this devastating disease. This project proposes to develop the protein misfolding cyclic amplification (PMCA) technology to detect with high sensitivity and specificity tau oligomers which are considered the key molecules responsible for neurodegeneration in AD. In this project we have put together the relevant technical and business expertise and secured the availability to key samples to permit the successful development, validation and approval of the test.